Efficacy of immunization with 4C-MenB in preventing experimental urethral infection with Neisseria gonorrhoeae.

Abstract:
Rates of sexually transmitted infections are on the rise in the United States, including those caused by
Neisseria gonorrhoeae. Antibiotic resistance in N. gonorrhoeae is also increasing and has been recognized as a
serious emerging public health threat by WHO and the US CDC. A vaccine against N. gonorrhoeae could help
combat the spread of antibiotic resistant N. gonorrhoeae, however, an effective vaccine for N. gonorrhoeae has
thus far eluded discovery. Individuals infected with N. gonorrhoeae do not develop immunity to subsequent
infection, limiting our understanding of the immune responses required for protection from infection. Mass
vaccination campaigns in New Zealand and other countries with vaccines against N. meningitidis serogroup B
made from outer membrane vesicles have been followed by reduced reported rates of N. gonorrhoeae
infections in those countries. The US FDA-approved N. meningitidis serogroup B vaccine (4C-MenB) contains
both N. meningitidis outer membrane vesicles and two recombinant antigens that are highly related to N.
gonorrhoeae homologs of the antigens. Our research team currently uses a unique human experimental
infection model to study N. gonorrhoeae in its natural host. Because the use of the 4C-MenB vaccine is not yet
widespread within the US, there is a unique and time-sensitive opportunity to test the effectiveness of this
vaccine in preventing N. gonorrhoeae using our human challenge model. The proposed clinical trial will also
allow us to study immune responses to the 4C-MenB vaccine and determine which responses are essential to
the protective effect of the vaccine. The current proposal requests support for the implementation of the
proposed clinical trial, which represents an important step in the development of an effective N. gonorrhoeae
vaccines.

Public health relevance
Project Narrative: Neisseria gonorrhoeae causes sexually transmitted infections, and rising levels of antibiotic resistance in the bacteria as well as rising case rates have created an urgent need for infection prevention. Observational studies in humans and preclinical work in mice indicate that a vaccine approved for use in the US to prevent infections caused by the related bacteria, Group B Neisseria meningitidis (4C-MenB), may provide partial protection against N. gonorrhoeae infection. We propose a randomized controlled trial with a unique experimental human infection model to test the effectiveness of 4C-MenB in preventing N. gonorrhoeae infection in men.